Identify common mechanisms of neurodegeneration between Alzheimer's disease and Down syndrome

Growing evidence indicates that Alzheimer's disease (AD) starts decades before its clinical manifestation and
that early clinical interventions are needed to effectively mitigate the progression of AD. However, the initial
triggers in the cascade of pathological events leading to AD remain elusive. Virtually 100% of people with Down
syndrome (DS) will show brain accumulation of amyloid-β (Aβ) and tau in their fifth decade of life. Despite these
striking data, little is known about the processes linking DS to AD. We postulate that dissecting the molecular
mechanisms driving AD pathology in DS patients will lead to a better understanding of the etiology of AD.
Published work and our preliminary data indicate that the mammalian target of rapamycin (mTOR) is hyperactive
in human and animal models of DS and AD. Further, we and others have shown that hyperactive mTOR signaling
facilitates the accumulation of Aβ and tau. Together, these novel and exciting findings may answer a fundamental
unresolved question: which event triggers the development of AD neuropathology in DS. The answer to this
question will unveil mechanistic changes linked to the etiology of AD. The overall hypothesis of this application
is that Dysfunctional TSC2 complex increases mTOR activity in DS, which in turn contributes to the
development of AD-like neurodegeneration by inducing necroptosis. To this end, we propose three Aims.
Aim 1 will test the hypothesis that dysfunctional TSC2 activity contributes to mTOR hyperactivity in DS.
Specifically, we will use three complementary approaches to systematically dissect the molecular pathways
leading to dysfunctional TSC2/mTOR axis in DS. These experiments will elucidate the signaling pathways
leading to mTOR hyperactivity in DS, which is a critical step towards understanding the link between DS and
AD. Specific Aim 2 will test the hypothesis that hyperactive mTOR signaling contributes to the development of
AD pathology in DS. Specifically, we will use three complementary approaches: (1) we will test the effects of
reducing neuronal mTOR activity on the development of AD-like phenotype in Ts65Dn mice; (2) we will determine
whether further increasing neuronal mTOR signaling in Ts65Dn mice, prior to the increase in Aβ levels,
exacerbates AD-like pathology and cognitive deficits; (3) we will use state-of-the-art isobaric tags for relative and
absolute quantitation (iTRAQ) technology to identify proteins that are differentially regulated by mTOR
hyperactivity in DS. These experiments will lead to a better understanding of the mechanistic relationship among
DS, mTOR, and AD. Specific Aim 3 will test whether hyperactive mTOR contributes to neuronal death by
activating necroptosis. The mechanisms that govern neuronal death in DS and AD remain poorly understood.
Our preliminary data show that necroptosis, a programmed form of necrosis, contributes to neurodegeneration
in AD and DS mouse models. We will use complementary experiments to modulate necroptotic signaling and
mTOR activity in animals and primary neurons. These experiments will lead to a better understanding of the
mechanism leading to cell loss in DS and AD and will identify new therapeutic targets for these two disorders.

Public health relevance
Alzheimer's disease is the most common form of dementia among the elderly and the sixth leading cause of death in the United States. This application aims at identifying the key molecular events linked to AD etiology. Elucidating these mechanisms will likely highlight several novel and clinically translatable targets; thus, aiding in the development of new treatment for AD.